Emerging XDR-TB: Host and Pathogen Contributions

DESCRIPTION (provided by applicant): The recent report of an extensively drug resistant (XDR) tuberculosis (TB) outbreak in Kwazulu-Natal, South Africa has alerted health authorities to the worsening global TB epidemic. TB control is increasingly compromised by the rise in drug resistant, multidrug resistant (MDR) and XDR-TB strains, reported in most countries surveyed. The goal of this research proposal is to explore host and pathogen factors that contribute to the failure of treatment of MDR-TB, ultimately leading to the emergence of XDR-TB strains. These studies will be done in South Africa, a country with some of the highest rates of TB worldwide. We will carry out two cross-sectional population-based studies of newly diagnosed MDR-TB patients from Gauteng Province, South Africa to characterize the nature and extent of the M/XDR-TB epidemic, to examine the diversity of MTB strains and drug resistance mutations represented in this population and to evaluate trends in the epidemic over the 5-year project period. We will also investigate the association between resistance to drugs in addition to INH and RIF and time to sputum culture clearance in patients undergoing treatment for MDR-TB. For these studies, two patient cohorts will be defined: Fast Responders (sputum culture clearance by the median time) and Slow Responders (failure to achieve sputum culture clearance by the median time). We will separately evaluate the impact of drug resistance (phenotypic/genotypic) that is pre- existing in the infecting bacillary population and drug resistance that is acquired de novo during treatment. Finally, we will explore selected nutritional and immunologic characteristics associated with poor response to treatment in the same patients undergoing treatment for MDR-TB. We will examine whether the time to sputum culture clearance and/or mortality observed among MDR-TB patients are associated with specific nutritional and/or immunologic profiles. The information gained from the cross-sectional studies can help to evaluate the extent to which XDR-TB may be attributed to primary transmission or acquired resistance and whether any M/XDR-TB strains are emerging in the region. The results of our clinical studies will help to elucidate factors that can contribute to poor response to treatment in MDR-TB patients, thereby fueling the increased incidence of XDR-TB. These data can inform current and future TB control strategies. As every additional M/XDR-TB patient is a public health hazard and a burden to the TB control program, our ability to identify factors that drive the epidemic will allow preemptive and targeted interventions. These may include improved treatment regimens, better approaches for monitoring patients during treatment, more intensive follow-up and other control strategies aimed at reducing the emergence of XDR-TB.

Public health relevance
PUBLIC HEALTH RELEVANCE: Multidrug resistant (MDR) and extensively drug resistant (XDR)-TB have been found in most countries surveyed. MDR- and XDR-TB are associated with high morbidity and mortality, prolonged treatment to cure, and increased risk of spread in the community. These studies will evaluate trends in incidence of M/XDR-TB in a region of South Africa and will additionally investigate various factors contributing to poor response to treatment in MDR-TB patients. Results of these studies can contribute to improved TB control strategies aimed at reducing the emergence of XDR-TB and the development of new therapeutic approaches for combating this deadly disease. Project Narrative Multidrug resistant (MDR) and extensively drug resistant (XDR)-TB have been found in most countries surveyed. MDR- and XDR-TB are associated with high morbidity and mortality, prolonged treatment to cure, and increased risk of spread in the community. These studies will evaluate trends in incidence of M/XDR-TB in a region of South Africa and will additionally investigate various factors contributing to poor response to treatment in MDR-TB patients. Results of these studies can contribute to improved TB control strategies aimed at reducing the emergence of XDR-TB and the development of new therapeutic approaches for combating this deadly disease. __SpecificAimsTextDelimiter__ A: Specific Aims The recent report of an extensively drug resistant (XDR) tuberculosis (TB) outbreak in KwaZulu Natal, South Africa has alerted health authorities worldwide to the worsening global TB epidemic (37). After what appeared to be an improvement in efforts to control TB, many countries are experiencing resurgence in rates of disease and disease mortality (90). A major strategy of TB control programs is case-finding and chemotherapeutic treatment to halt the spread of infection. Unfortunately, the effectiveness of treatment is increasingly compromised by the global rise in drug resistant, multidrug resistant (MDR) and XDR strains of M. tuberculosis (MTB). Both MDR- and XDR (M/XDR)-TB have been reported in most countries surveyed (90). Drug resistance in MTB occurs primarily via spontaneous mutations, which are selected for under conditions of poor treatment compliance, use of sub-optimal treatment regimens, and intermittent use of drugs. Once drug resistance is established, TB is significantly more difficult to treat and eradicate, due to loss of the first line, most efficacious drugs (46, 57). Also, in patients undergoing treatment for MDR-TB, heterogeneous populations of both resistant and susceptible bacilli (heteroresistance) can arise, greatly increasing the chances of selecting for additionally resistant organisms and potentially contributing to treatment failure (53, 76, 91, 92). Nonetheless, recent reports have suggested that, even in resource-poor settings, it is possible to cure a significant percentage of XDR-TB patients under stringently controlled treatment conditions (12, 22, 57). However, successful treatment in these reports was dependent upon a detailed knowledge of resistance to both first- and second-line TB drugs and careful monitoring of patients during the course of therapy. The goal of this research proposal is to explore host and pathogen factors that contribute to the failure of treatment of MDR-TB, ultimately leading to the emergence of XDR-TB strains. These studies will be done in South Africa, a country with some of the highest rates of TB worldwide. We will first carry out two cross-sectional population-based studies of newly diagnosed MDR-TB patients from Gauteng Province, to characterize the nature and extent of the M/XDR-TB epidemic, to examine the diversity of MTB strains and drug resistance mutations represented in this population and to evaluate trends in the epidemic over the 5-year project period. We will then investigate the association between resistance to drugs in addition to INH and RIF and time to sputum culture clearance in patients undergoing treatment for MDR-TB. For these studies, two patient cohorts will be defined: Fast Responders (sputum culture clearance by the median time) and Slow Responders (failure to achieve sputum culture clearance by the median time). We will separately evaluate the impact of additional drug resistance (phenotypic/genotypic) that is pre-existing in the infecting bacillary population at the time of initiating treatment for MDR-TB and drug resistance that is acquired de novo during treatment. Finally, we will explore selected nutritional and immunologic characteristics associated with poor response to treatment in the same patients initiating treatment for MDR-TB. We will examine whether the time to sputum culture clearance and/or mortality observed among MDR-TB patients are associated with a specific nutritional and/or immunologic profile. The information gained from these studies will help to elucidate factors that can contribute to poor response to treatment in MDR-TB patients, thereby fueling the increased incidence of XDR-TB. These data can inform current and future TB control strategies. As every additional M/XDR-TB patient is a public health hazard and a burden to the TB control program, our ability to identify factors that drive the epidemic will allow preemptive and targeted interventions. These may include improved treatment regimens, better approaches for monitoring patients during treatment, more intensive follow-up and other control strategies aimed at reducing the emergence of XDR-TB. Specific Aim 1: Conduct a population-based study of MDR-TB in Gauteng Province and utilize the collected MTB patient isolates to characterize the strains and drug resistance profiles circulating in the population and to understand the progression of the epidemic over the 5 years of the project. a. Conduct two population-based cross-sectional studies of MDR-TB patient isolates in Gauteng Province, at least 3 years apart (Years 1 and 4); Collect and bank patient isolates. b. Characterize the collected MDR-MTB isolates by molecular epidemiologic methods (e.g. IS6110- RFLP) to evaluate strain diversity and identify clusters indicative of possible transmission. Determine sequences of common drug resistance genes and phenotypic resistance. c. Correlate the data from the two cross-sectional studies to identify trends over time in the relative proportions of MDR, MDR-plus and XDR-TB isolates in the population, and in the strain diversity and level of clustering present in these drug resistant MTB cohorts. Specific Aim 2: Examine, in newly diagnosed MDR-TB patients (HIV-positive and HIV-negative cohorts), the predictive value of additional drug resistance present in the infecting bacillary populations at baseline on sputum culture conversion at the median time (4 months) after initiating MDR-TB treatment. Collect monthly sputum cultures over the course of treatment for MDR-TB to evaluate the impact of de novo acquisition of additional drug-resistance on sputum culture conversion. a. Culture monthly serial patient sputum specimens and bank MDR-MTB samples to determine clonality of the infection in each patient by IS6110 RFLP typing. b. Culture and bank 10 single colonies of MTB isolated directly from sputum specimens obtained at baseline (initiation of treatment) to identify the presence of heteroresistant populations of bacilli. c. Using banked monthly cultures, determine the initial baseline drug resistance profile and/or additional drug-resistance mutations acquired during treatment by direct DNA sequencing and by the Ibis T5000 assay (a novel multiplex PCR-mass spectrometry assay). d. Using banked cultures from single colonies, determine the proportion of heteroresistant organisms present at baseline by direct DNA sequencing and by the Ibis T5000 assay. e. Correlate the results obtained with sputum culture conversion to identify parameters that are predictive of Slow (sputum culture positive at 4 months after initiating treatment) versus Fast (culture negative at 4 months) Responders among HIV-positive vs. HIV-negative patients undergoing treatment for MDR-TB. Specific Aim 3: Examine the predictive value of nutritional status and host immunity on sputum culture conversion at the median time (4 months) after initiating treatment for MDR-TB in the same cohort of patients defined in Specific Aim 2 to determine nutritional and/or immunologic parameters associated with bacillary clearance/treatment failure. a. Evaluate the nutritional status of the HIV-negative and HIV-positive patient cohorts defined at baseline and during treatment for MDR-TB. b. Evaluate the profiles of soluble immune mediators in plasma samples obtained from the cohort of HIV- negative patients at baseline and during treatment for MDR-TB. c. Identify the cytokine expression signatures, differentiation profiles and functional status of mycobacteria-specific T cells and Natural Killer (NK) cells by flow cytometry in blood samples obtained from the cohort of HIV-negative patients at baseline and during treatment for MDR-TB. d. Correlate the results obtained with sputum culture conversion at the median time after initiating treatment to identify nutritional and/or immunologic parameters that are predictive of Slow versus Fast Responders among patients undergoing treatment for MDR-TB. The proposed studies will be carried out in South Africa, where TB incidence is high and there is a high diversity of strains circulating in the population and relatively low, yet significant, prevalence of MDR- and XDR- TB. The project will be in collaboration with Dr. Gerrit Coetzee and Prof. Hendrik Koornhof of the National Institute of Communicable Diseases (NICD) at the National Health Laboratory Services (NHLS) in Johannesburg, South Africa. Dr. Coetzee is the Head of the National TB Reference Laboratory, and Prof. Koornhof is Professor of Microbiology at WITS University. Dr. Martin Grobusch, Professor and Chair of Infectious Diseases at WITS University, will act as the Clinical Director for studies carried out at the Sizwe Tropical Diseases Hospital in Johannesburg, the referral hospital for treatment of M/XDR-TB patients in Gauteng Province. Dr. Clive Gray, Head of the AIDS Research Unit at the NICD, will direct the immunologic studies. Dr. Kerstin Klipstein-Grobusch, Associate Professor and Head of Epidemiology and Biostatistics at the School of Public Health, WITS University, will be responsible for directing the nutrition studies at Sizwe Hospital.